Adminstrative Supplement-Chemical Biology of Nitroxyl (HNO) in Bacillus Subtilis

Project Summary
Document not needed: Not Applicable

Public health relevance
Narrative Document not needed: Not Applicable